Connecticut Department of Consumer Protection, Food & Standards Division Grant Application: Developing a Food Protection Rapid Response Team (RRT): RFA-FD-18-001

Project Summary The Connecticut Rapid Response Team Project will complement the primary mission of the Departments of Public Health, Consumer Protection and Agriculture, notably to protect and promote public health in the commerce of food. Responding to food emergencies is a key part of that mission. The objective of this project therefore is to implement a more efficient, uniform, and effective response to State and Region-wide food emergencies across multiple jurisdictions. Our plan to accomplish that objective is three-fold, first to hire a coordinator that will in effect report to the three agencies. Second, use sub-awards to support the establishment of a cross-jurisdictional task force to work on integration, training and development of the Connecticut RRT, encompassing core elements related to collaboration, communication, policies and procedures, and resources in each phase of a foodborne illness, from preparation, surveillance/detection, investigation, mitigation/control thru to response/prevention. Finally by promoting region-wide collaboration as a mentee and exercise participant with Massachusetts (mentor) and Rhode Island, all within the context of established RRT Best Practices.

Public health relevance
Connecticut – RRT Project Narrative Our plan is to hire an RRT coordinator who in conjunction with sub-awards will work to support the establishment of a cross-jurisdictional task force to work on integration, training and development of the Connecticut RRT, and to address State and region-wide issues through an interagency task force. The RRT task force will be modeled on RRT core elements and best practices related to collaboration, communication, policies and procedures, and resources in each phase of a foodborne illness, from preparation, surveillance/detection, investigation, mitigation/control thru to response/prevention. We plan on partnering with the Departments of Public Health (DPH) Agriculture, and other agencies, to establish an overall coordinator with the understanding that we are working collaboratively with our State and local partners to establish an effective and efficient Rapid Response Team to respond to food emergencies. We have also entered into a mentorship arrangement with the Rhode Island Department of Public Health and have already participated in a region wide exercise with Massachusetts and Rhode Island in Providence. Work Planning In accordance with adapted prerequisites established in the Partnership for Food Protection “Model for Local Federal/State Planning and Coordination of Field Operations and Training” (with some necessary modification) after hiring staff the following steps will be undertaken: 1. Establish formal communication protocols 2. Build on/establish Joint Goals and Objectives based on RRT Best Practices for the task force 3. Develop a plan to make best use of existing resources while minimizing duplication of efforts 4. Identify training needs & gaps, both for the team and partners – federally, regionally, and locally 5. Discuss trends and triggers related to food borne illness, response strategies, and identify enforcement tools available to each partner 6. Discuss Continuity of Operations in the event of an emergency 7. Coordinate resources to respond to emergencies 8. Continue to participate in region-wide and State-wide exercises 9. Establish quarterly meeting schedules for RRT partners on the State, local and Federal levels and to discuss progress as measured by goals established in the Research Strategy of the grant 10. Establish and participate in local, State, region and national exercises.